Lifestyle associated reactive metabolites and their negative impact on breast cancer risk

PROJECT SUMMARY/ABSTRACT
The focus of this study is on early life factors and their effect on mammary development during puberty and
how they relate to increased breast cancer risk. At this time we do not understand what biological changes
occur during pubertal mammary development which leads to a greater risk of developing cancer in later life.
Identifying the molecular mechanisms that cause aberrant pubertal mammary development may lead to
defined strategies to reduce breast cancer burden in later life.
As our bodies use the sugars that we consume for energy they generate waste chemicals known as
metabolites. One such group of metabolites is known as advanced glycation end products or AGEs for short.
Critically apart from their production as a result of the breakdown of sugar, AGE’s are also formed through the
ingestion of food and by external environmental factors such as lack of exercise. Changes in this dynamic
equilibrium causes protein dysfunction, protein crosslinking, decreased genetic fidelity, altered gene
expression profiles and aberrant cell signaling.
Our studies have identified in animal models that a diet high in AGEs significantly alters how the breast
develops during puberty. The tumor microenvironment is now becoming recognized as having a major role in
facilitating both mammary development and cancer progression, and that, alterations in stromal cell signaling
can precede epithelial cell alterations and act as drivers of the tumorigenic process. Critically, the high AGE
diet produces architecture in the breast that resembles pre-neoplastic lesions with hyper-proliferative structures
and increased levels of stromal cells. We also show that AGE levels are significantly elevated in the circulation
and tumor tissue of breast cancer patients and that AGE treatment alters cancer associated signaling
pathways to promote breast tumor growth.
This study aims to define the mechanism by which a high-AGE diet causes the dysregulation of the mammary
gland during puberty (SA1) and adulthood (SA2) and will ask if the changes observed lead to a higher risk of
breast tumor formation and growth (SA3).
A greater mechanistic understanding of the link between AGE intake during puberty and increased breast
cancer risk may define novel potential strategies for lifestyle and pharmacological intervention aimed at
reducing breast cancer risk at a defined window of susceptibility.

Public health relevance
PROJECT NARRATIVE Data support the notion that critical events during pubertal mammary development may influence the breast microenvironment to increase breast cancer risk and promote tumor growth. Advanced glycation end-products (AGEs) are reactive metabolites produced during normal metabolism. Critically, disease states and lifestyle factors such as a sedentary lifestyle, obesity and poor diet increase AGE levels in the body. Our studies indicate that a high AGE diet during puberty disrupts mammary gland development to leave structures in the breast indicative of pre-neoplastic lesions. The objective of this study is to examine if increases in AGE levels during puberty represents a critical event during mammary development that increases future breast cancer risk and promotes tumor growth.